GenomeSpace: community web environment for analysis across diverse genomic tools

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text. N/A

Public health relevance
PUBLIC HEALTH RELEVANCE: The GenomeSpace community resource puts the universe of diverse genomic analysis tools within the reach of all biomedical researchers. Through the integrative analysis of genomic data from diverse sources and types, GenomeSpace users will be able to address a variety of problems at the forefront of biomedical research including patient diagnosis and prognosis, identification of new drug targets, and understanding biological mechanisms.